Molecular mechanisms underlying HIV & Cocaine-mediated microglial activation: Targeting NLRP3 inflammasome

Summary: The parent grant (DA050545) focuses on assessing the role of microglial inflammasome NLRP3 in
the context of neuroinflammation mediated by HIV and cocaine use. Since people living with HIV (PLWH) are
now enjoying longer life-span, owing to effective combinatorial antiretrovirals, it is no surprise that there is an
emerging surge of age-related comorbidities intersecting with the already existent HAND symptomatology in
these individuals. In light of this, clinicians are seeing a rise in premature aging and Alzheimer’s-like phenotype
in PLWH. Interestingly, in keeping with the clinical findings, studies from our lab have also demonstrated the
accumulation of toxic amyloid deposits in the sections of brains from SIV-infected macaques as well as those
from HAND patients with cocaine exposure (from NNTC) and, in the brains of HIV Transgenic rats exposed to
cocaine (preliminary studies). Furthermore, in our recently reported cell culture study, we have also
demonstrated that activated NLRP3 inflammasome generated from HIV Tat-activated microglia can shuttle to
the bystander neurons via the extracellular vesicles (EVs), and unpublished data showed these EVs lead to
upregulated expression of toxic amyloid proteins in the neurons. Taken together, we thus hypothesize that HIV
Tat and cocaine-mediated activation of microglial NLRP3 (parent grant) could be shuttled through the microglial
EVs to the recipient neurons to induce toxic amyloids and senescence mediators, which, in turn, could be
detected as biomarkers in neuronal enriched EVs isolated from the plasma.
While the focus of the parent grant
is on understanding the role of activated NLRP3 inflammasome in the context of HIV Tat, and cocaine, the
supplement aims to extend these studies to already available, archived plasma and brain samples from groups
of SIV-infected rhesus macaques administered with/without cocaine for assessing the amyloid pathology and
senescence phenotype in the brains of these animals and brain-derived neuronal EVs in the plasma. We will
also correlate the expression of microglial NLRP3 in the brain with NLRP3 in plasma-enriched microglial EVs
and expression levels of aging/AD cargos in the plasma-enriched neuronal EVs.

Public health relevance
Narrative In the proposed administrative supplement, we will use archived brain and plasma samples from groups of SIV- infected rhesus macaques, with or without cocaine administration, to assess amyloid pathology and senescence phenotype in their brains. Additionally, we will examine brain-derived neuronal extracellular vesicles (EVs) in the plasma and correlate the expression of microglial NLRP3 in the brain with NLRP3 in plasma microglial EVs, along with the expression levels of aging/AD cargos in the neuronal EVs. Our goal is to identify biomarkers of HAND and the AD/Aging phenotype.